Dosage Sensitivity of Gene Expression in Pluripotent Stem Cells in the context of Down Syndrome

PROJECT SUMMARY Gene dosage and regulation of gene expression levels are important to proper maintenance of cellular function, yet how these levels are coordinated and balanced is little understood. Events such as segmental duplications and aneuploidy can disrupt the dosage balance of gene expression; specific genes sensitive to this change can lead to disease. Understanding of dosage sensitivity may provide insight into these types of complex genetic disorders but this has not been comprehensively studied in humans. To investigate dosage sensitivity, Down syndrome (DS) may prove to be both a useful and important disease model, as it is the most common form of aneuploidy in humans, with 1 in 700 live births. DS is caused by trisomy of chromosome 21 (chr21) and it is unknown how many genes are major contributors of DS pathology. There are over 400 genes on chr21 but it is likely that only a subset of dosage sensitive genes is responsible for the pathology. Additionally, it can be difficult to discern which chr21 genes are likely to be dosage sensitive from transcriptomic studies. Thus, additional study on genome-wide effects of the extra chr21 in DS is needed as well as a better method to identify and prioritize chr21 dosage sensitive genes. In this proposal, I seek to study dosage sensitivity in the context of Down syndrome, first, by investigating transcriptome-wide effects of trisomy 21 through the use of induced pluripotent stem cells (iPSCs), second, examining the contributions of candidate chr21 dosage sensitive genes involved in DS pathology, and finally, through the use of bioinformatics analysis, extend methods of identifying and prioritizing candidate chr21 dosage sensitive genes. AIM 1: Recently, our lab has developed a chromosomal silencing system in iPSCs through the use of an XIST transgene, comprehensively silencing the extra chr21 in DS iPSCs. I will use this DS iPSC silencing system to study the dosage effects on the transcriptome by comparing the extra chr21 silenced and non-silenced DS iPSCs. This will allow us to observe the earliest and direct biological effect of trisomy silencing which will be important to understanding DS pathogenesis. AIM 2: With the advent of CRISPR technologies, we are able to precisely modulate gene dosage in DS iPSCs cells. Using candidate chr21 genes in DS identified by preliminary microarray data, I will generate single allele knockout DS iPSC lines to determine the single gene contributions to DS cellular phenotypes. With the specific genetic context of DS, I will be able to examine the underlying mechanisms that are relevant to DS pathology. AIM 3: It has been suggested that dosage sensitivity is correlated with low expression variability, but this has not been extensively studied in humans. While a few predictive models for dosage sensitivity exist, they are not comprehensive and did not include expression variability as a parameter. Therefore, I will take a genome-wide approach to examine the gene expression of known dosage sensitive genes, incorporating it into an existing predictive model to better prioritize chr21 dosage sensitive genes.

Public health relevance
PROJECT NARRATIVE In this project, I will study the concept of dosage sensitivity, in which some genes are sensitive to change in gene expression and can lead to disease. I will study dosage sensitivity through the lens of Down syndrome using both molecular cell biology and computational methods to determine which chromosome 21 genes are major contributors to the cellular pathology. This will provide further insight into Down Syndrome pathology and our understanding of dosage sensitivity as well as other complex genetic disorders.